Effects of Noise and Other Exposures on Auditory Functioning in Post-9/11 Veterans: NOISE Study 3.0

Little is known regarding the epidemiology, etiology, pathophysiology, and comorbidities of hearing loss and
tinnitus in the military population. The Department of Veterans Affairs (VA) is consequently unable to predict
the risk of auditory disorders in Service members exposed to noise. Compounding this problem, many other
military and non-military exposures can cause auditory injury, including solvents, blasts and other sources of
traumatic brain injury (TBI), and certain other injuries and medical conditions. Non-military (e.g., recreational)
or post-military exposures (i.e., Veterans' occupational exposures) may also contribute to long-term risk. It is
critical to attain a fundamental understanding of the epidemiology and pathophysiology of tinnitus and hearing
loss, as well as their interrelatedness. Such an understanding could help identify individuals at risk for auditory
injury, and ultimately lead toward much-needed rehabilitation methods that target the underlying causes.
In 2012, in response to recommendations made by the Institute of Medicine (IOM; now the National Academies
of Medicine) in their congressionally-mandated report titled, “Noise and Military Service: Implications for
Hearing Loss and Tinnitus,” we assembled a team of audiology, epidemiology, and health services researchers
at the VA Rehabilitation Research & Development (RR&D) National Center for Rehabilitative Auditory
Research (NCRAR) to design a longitudinal study focused on auditory health in recent Veterans. The Noise
Outcomes In Service members Epidemiology Study (“NOISE Study”) was funded in 2013 [Congressionally
Directed Medical Research Programs (CDMRP) grant #W81XWH-12- PRMRP-IIRA]. The study enrolls
Veterans within 2.5 years of military separation, allowing us to measure their military exposures within a
reasonable recall period. In 2014, the Department of Defense (DoD) Hearing Center of Excellence (HCE; San
Antonio, TX) was added as a second site to increase enrollment and to expand our target population to include
active-duty military Service members. Enrollment at the HCE began in June 2015. The present proposal
requests funding to continue study activities for the next 4-year period for the NCRAR site. (Should the HCE
not receive continuation funding from the DoD, their participants will be followed by the NCRAR team.)
Since the NOISE Study's inception, baseline data have been collected on 644 Veterans at the NCRAR and
373 Service members at the HCE (1,017 participants enrolled across the two sites). The baseline examination
includes a full audiologic test battery with an extensive survey component. Participants complete annual follow-
up surveys (online) to capture ongoing exposures and any changes in health and functioning. The in-person
audiologic examination is repeated every 5 years, allowing us to identify changes in auditory function over time
and contrast those changes with Veterans' past military exposures and/or ongoing non-military exposures. For
the proposed continuation study (NOISE Study 3.0), we will expand data collection to address current and
evolving interests in the field of auditory health, to include focusing on blast as a risk factor for outcomes of
auditory functioning, and testing for central auditory processing disorder (CAPD) and cochlear synaptopathy.
These efforts will produce an unprecedented epidemiologic dataset revealing cross-sectional and longitudinal
associations between a wide range of exposures, medical and mental health conditions, peripheral auditory
function, central auditory function, and tinnitus. Deliverables include a series of research reports containing
analyses and recommendations with a special focus on: estimates of incident tinnitus and hearing loss
following military service and identifying sub-populations at-risk; individual and population-level trajectories of
hearing and tinnitus; estimates of the association between cochlear synaptopathy and central auditory
dysfunction with incident tinnitus and perceived hearing ability; and confluence of auditory dysfunction and
mental distress on quality of life in post-9/11 Veterans. Clinical deliverables include validation of surveys for
capturing noise and chemical exposures and distinguishing occasional from chronic tinnitus.

Public health relevance
The purpose of the next phase of this epidemiologic project known as “Noise Outcomes In Service members Epidemiology Study 3.0” (NOISE Study 3.0) is to gather information from Veterans recently separated from military service, and active duty Service members, about their military and non-military noise exposures, other relevant military and non-military exposures (e.g., ototoxicants, bombs/blasts, TBIs), tinnitus, hearing loss, and other hearing-related health concerns. Over 1,000 participants have completed baseline testing, and participants complete annual follow-up assessments. The proposed study will continue this longitudinal study and expands the test battery to add behavioral and electrophysiologic measures to test the integrity of multiple stages of auditory processing. The goals of NOISE Study 3.0 are relevant to the VA as they pertain entirely to Veterans' current and future health care needs. This research will offer unparalleled insight into the hearing health of Veterans, informing prevention, intervention, and rehabilitation efforts at the VA.